Global Perspectives on Implications of Developmental Science to Address Adolescent Resilience to Sociocultural and Ecological Challenges

Project Summary/Abstract
The COVID-19 pandemic was a great revelation that we live in a world without borders in which the collective
collaboration of research scientists can successfully develop a vaccine to disrupt even a devastating global
crisis. It is this need for global team science and collaborations that served as the impetus for this application.
The Global Perspectives on Developmental Science to Address Adolescent Resilience and Well-Being in the
Face of Sociocultural and Ecological Challenge conference is co-sponsored by the Society for Research on
Adolescence (SRA) and the International Consortium on Developmental Science Societies (ICDSS) and
designed to meet five goals. 1) To integrate cutting-edge global research regarding socio-cultural, contextual,
and ecological challenges confronting today’s adolescents and guide policies, programs, and practices that
best support resilience and well-being in youth. (2) To introduce and provide training in resource-and-
expertise-sharing strategies that translate global approaches to the study of adolescent resilience in ways that
benefit families and communities locally. (3) To increase awareness of the value of establishing a global
research agenda for the Developmental Science of Adolescence among both US and non-US scholars as a
pathway to enhance our understanding of commonalities and differences in youth resilience and well-being. (4)
To support early and mid-career global scholars in identifying and overcoming barriers to international research
- particularly in terms of collaboration, funding, and publishing. (5) To disseminate a manualized, scalable “best
practices” approach to conference training by evaluating and expanding research and mentorship models
capable of advancing a global collaborative Developmental Science of Adolescence. This single-day meeting
will host an international audience through a highly interactive hybrid platform, prioritizing opportunities for in-
person engagement, collaboration, and reflection. We will also create action plans for enhancing and
sustaining a network of global scholars focused on adolescent development into the future. This conference
will provide an opportunity to critique and discuss recently emerging studies of the COVID-19 pandemic and
other ecological threats and practices for building a more diverse and inclusive global science that will advance
our broader understanding of youth resilience and well-being around the world. Platforms include panel-led
large group discussions, flash talks, small group exercises, wellbeing exercises, and design-based strategies
to spur innovation and scholar interaction.

Public health relevance
Project Narrative Responsive to the call for global team science and collaboration, the Global Perspectives on Developmental Science to Address Adolescent Resilience and Well-Being in the Face of Sociocultural and Ecological Challenge conference aims to integrate cutting-edge research regarding socio-cultural and ecological challenges confronting today’s adolescents and to guide policies, programs, and practices that best support resilience and well-being in youth around the world. To springboard the establishment of a sustainable community of global scholars, this conference provides a foundation for the creation of a global science research network in adolescent resilience and well-being, contextually- and culturally-relevant theoretical frameworks and methods for advancing that science, and support for a diverse cadre of scholars across the career trajectory to engage in and translate this work in ways that benefit local families and communities around the world.